Supporting Multidisciplinary Achievement in Respiratory Research Training (SMARRT)

This proposal is designed to address the critical workforce need for physician and scientist investigators in respiratory related disorders. To develop such investigators, we seek support for an educational curriculum designed to meet the special research training needs of emerging, talented pulmonary, allergy, or critical care medicine postdoctoral PhD trainees and MD fellows. The program will include high standards of research that span the entire spectrum comprising fundamental discovery science, early translational research, clinical investigations, population science research, and translational research, thereby moving fundamental discoveries into clinical and public health practice in real-world settings. We aim to ensure success by proposing an innovative program that contains both fundamental core elements yet adapts to the individual needs of each trainee. Our program builds on: 1- Lessons learned from our own experience in running a successful KL2 program with a high rate of transitioning scholars to independent academic careers at an early stage, 2- A highly successful innovative research-oriented medical school program, 3- Strong pulmonary, allergy, and critical care MD fellowship programs and strong PhD doctoral programs which provide a large pool of qualified applicants, and 4- Proven strategies from published national studies on mentorship and approaches recommended by these studies to attract and retain promising young people. Our T32 Program has the following AIMS: Aim 1: To provide postdoctoral (MD, PhD, MD/PhD) trainees who are engaged in pulmonary, allergy or critical care medicine and research with multidisciplinary didactic training, coupled to a team mentored research experience. Aim 2: To enhance the ability of trainees to work as part of an integrated, multidisciplinary team by developing a knowledge base and skills in research methods, communication skills, professionalism, the ethical conduct of research and rigorous analysis of reproducible findings. Aim 3: To recruit, retain and accelerate the independent career development of a pool of young investigators with the multidisciplinary skills necessary for an independent research career in basic, clinical, translational or population health research. Once they complete our highly adaptive program, trainees will have the knowledge and skills to pursue outstanding cutting-edge research careers and will be able to recognize the importance of different research paradigms, ranging from molecular medicine to public health sciences, for rapidly translating scientific discoveries into better diagnostics and therapeutics. This T32 proposal will fill an important gap in our existing research training portfolio by providing structured research training. We anticipate that trainees supported by this program will be engaged in experimental approaches, form mentor-trainee relationships and gain the additional research experience needed to enhance competitiveness for independent research and career development awards.

Public health relevance
PROJECT NARRATIVE This innovative new proposal is designed to supplement the education of postdoctoral trainees with MD, PhD, or equivalent degrees in the areas of pulmonary, allergy, or critical care medicine by supporting research in heart, lung, blood, and sleep related disorders. We built a research training curriculum to meet the special needs of these trainees and expose them to high standards of multidisciplinary medical research. Once they complete our highly adaptive program, trainees will have the knowledge and skills to pursue outstanding cutting-edge independent research careers that will give them the ability to rapidly translate scientific discoveries into better ways to diagnose and treat disease.